Research & Methods Core

PROJECT SUMMARY/ABSTRACT
The MATCHES (Making Telehealth Delivery of Cancer Care at Home Effective and Safe) Telehealth Research Center aims to build the evidence base necessary to establish best practices for telehealth-supported cancer care. It will execute nimble, rigorously designed clinical trials investigating whether and how telehealth can enable more cancer care to be safely and effectively provided in patients’ homes. The Research & Methods Core (RMC) is instrumental to the MATCHES research theme: focusing on the development of methods to integrate complex streams of multi-level data from asynchronous and synchronous encounters so as to evaluate the effectiveness and impact of telehealth. Specifically, the RMC will generate, refine, validate, and disseminate novel research methods and outcome measures for the evaluation of telehealth in oncology, including digital biomarkers based on digitally captured data and electronic patient-reported outcomes. These activities will directly advance our goal of developing a paradigm for personalized cancer care delivery. To this goal, the RMC brings high-level expertise, strong infrastructure, extensive resources, and immediately relevant experience in data management, mixed-methods research, biostatistics, advanced predictive analytics (e.g., machine learning, artificial intelligence), and clinical trial design. The RMC will be led by Katherine Panageas, DrPH, a biostatistician with deep expertise in trial design and health services research methods. She has led statistical coordinating centers for multiple large projects, including clinical trials and cancer control studies, and has evaluated complex care delivery innovations. The aims of the RMC are: 1) to provide high-quality data management for the development of research methods in telehealth, 2) to provide methodological and biostatistical support for the cluster-randomized Pragmatic Trial and for pilot studies evaluating MSK@Home,3) to develop and apply novel statistical and research methods to aid evaluation of telehealth-supported cancer care delivery research and to train early-career investigators in these methods, and 4) to disseminate data, knowledge, and resources via user-friendly, open-source algorithms to accelerate broader implementation of telehealth-enabled home-based care. The RMC will develop a framework for processing and analyzing the multiple data streams generated in the context of telehealth-supported cancer care, as well as play a key role in reviewing and evaluating the research progress of the Center. It will also support the Pragmatic Trial and pilot studies and lead the selection and deployment of further telehealth pilot projects. The RMC will work closely with the MATCH-Light Training Unit of the Administrative Core to train junior investigators in research methods to advance telehealth research to drive personalized and efficient oncology care and research.